TRIAZOLE THERAPY OF PRIMARY PULMONARY COCCIDIOIDMYCOSIS

To determine whether itraconazole therapy is beneficial in the treatment of early pulmonary coccidioidomycosis. To ascertain improvement subjectively as well as radiographically and by other objective means.